Penn's Center of Excellence in Cancer Communication Research

DESCRIPTION 4

Public health relevance
Penn's CECCR II is committed to building the nations's cancer communication agenda. Each of the major projects is specifically linked to clinical services and is intended to produce actionable recommendations. Translation to practice and to policy are built into the Center and its institutional links. Penn is also proud of the Center's history and promise in developing the next generaltion of cancer communication researchers